Treatment of Consequences of Female Genital Cutting

Project Summary/Abstract
The National Pain Strategy notes the importance of addressing pain in minority populations to reduce health
disparities. One such population is female refugees who have been victim to female genital cutting (FGC) ---
which is known to cause sexual pain. The objective of the proposed research is to collect empirical data to (1)
inform the conceptualization of sexual pain and other outcomes among Somali women living in Minnesota who
have experienced FGC, (2) promote healthcare practices that minimize sexual pain, and (3) develop decision-
making tool(s) and education seminars driven by study findings. The majority of Somali girls undergo
infibulation when originally cut, which involves stitching the vaginal opening shut. Deinfibulation (i.e. opening
the circumcision/infibulation scar) may decrease pain and is necessary before vaginal birth. It is recommended
before labor and delivery; however, many patients wait until labor and delivery to undergo deinfibulation –thus
increasing a risk in tears. Little is known about how sexual pain and sexual function are impacted by the timing
of deinfibulation. To better understand sexual pain in relation to FGC, we will rely upon conceptual models that
utilize a biopsychosocial approach, integrating biological, psychological, and cultural considerations. These
models include fear-avoidance, endurance, and resilience. We will partner with a community-based
organization (SoLaHmo) and two large medical clinics serving Somali American women to conduct 75
qualitative interviews, 300 computer assisted surveys of Somali-American married women 18-45 years who
have experienced FGC to accomplish the following aims: Aim 1: Qualitatively investigate sexual pain
characteristics and meaning ascribed to sexual pain. Aim 2: Establish reference levels using descriptive
statistics to quantify sexual pain characteristics (presence, frequency, intensity), sexual function, pain
responses (fear avoidance, endurance, resilience), and moderator variables (acculturation and shared decision
making) in this population. Aim 3: Among women who have vaginally delivered one or more babies, determine
if sexual pain characteristics and sexual function are associated with the timing of deinfibulation with first child.
Aim 4: Among women reporting sexual pain in Aim 3, determine if pain responses (fear avoidance, endurance,
resilience) are associated with sexual pain and sexual function, and whether these associations are modified
by degree of acculturation --- while adjusting for timing of deinfibulation. The long-term goal is to identify
mechanisms that will lead to better pain management in this population. Completion of these novel study aims
will generate information to develop evidence-based and culturally- sensitive medical and psychological
interventions for women who have undergone FGC.

Public health relevance
Project Narrative Due to recent immigration patterns, there has been a large increase in girls and women in the U.S. healthcare system who have experienced female genital cutting (FGC; a.k.a. female circumcision) – a common outcome of FGC is sexual pain. The proposed research project will investigate factors that may contribute to increased risk of developing chronic sexual pain among circumcised Somali American women living in Minnesota. The overall goal is to gather information that may be used by mental health and medical professionals to provide culturally-sensitive and empirically-informed healthcare.